Evaluation of Natural Experiments of Nutrition Assistance to Prevent and Control Diabetes among Low-Income Communities

ABSTRACT/PROJECT SUMMARY
LIFESPAN-D (LongItudinal Food security Experiments via SuPplemental Assistance with Nutrition for Diabetes),
is the first evaluation of large-scale natural experiments to determine the health and cost-related effects of
nutrition assistance (SNAP and WIC) on T2D outcomes across the lifespan. Food insecurity (FI) is a common,
potent factor in the development of type 2 diabetes mellitus (T2D) among low-income populations in the US, and
a contributor to socioeconomic, racial and ethnic disparities. FI pressures people to consume low-cost
carbohydrate- and energy-rich foods that increase the risk of T2D and makes its clinical management more
challenging; creates chronic stress; presents a “competing demand” that crowds out attempts to engage in other
health-promoting behaviors; and forces individuals with T2D to make difficult choices between paying share of
costs for medicine, monitoring or healthcare vs. paying for nutritious food or other essential needs—creating a
Sophie's Choice that can worsen T2D controls and accelerate complications. FI populations are also
predisposed to trans-generational elevated risk for T2D, in part, through in utero metabolic programming. FI has
been associated with increased progression from prediabetes to T2D, increased gestational diabetes (GDM),
and increased hospitalizations for glycemic events among low-income populations with T2D. FI can be reduced
and dietary quality improved through nutrition assistance programs, yet whether such programs can improve
T2D-related outcomes among vulnerable populations remains an unanswered question. We address this critical
question across the lifespan, studying two natural experiments in nutrition assistance policy to address the
question: To what extent, and among which populations, does reducing FI through nutrition assistance affect
T2D and gestational diabetes (GDM) rates, T2D control, and T2D complication-related ED visits and
hospitalizations? And what are the health economic implications? First, we will evaluate a new California
statewide policy that allows individuals who receive SSI - a federal income supplement program to help aged,
blind and disabled people of low income – to now be concurrently eligible for the federal Supplemental
Nutrition Assistance Program (SNAP). Using a quasi-experimental design and statewide longitudinal datasets,
we will measure cardiometabolic control, ED visits and hospitalizations for complications among low-income
individuals with T2D, as well as incident T2D among individuals with prediabetes. Second, we will evaluate a
new California policy within the federal Nutrition Program for Women, Infants, and Children (WIC) that is shifting
WIC from a paper voucher to an Electronic Benefits Transfer (EBT) card system that will increase uptake of WIC
benefits. Using a quasi-experimental design and statewide and national datasets, we will measure effects of
eWIC on perinatal outcomes, including GDM and gestational weight gain among mothers and birth outcomes of
their offspring. Third, we will estimate the cost-effectiveness of the policies (SSI-SNAP and WIC policy),
incorporating ED visits, hospitalizations and long-term care costs and projected costs averted related to better
cardiometabolic control and lower T2D incidence.

Public health relevance
PROJECT NARRATIVE (in layperson language) The research projects contained in LIFESPAN-D will determine the health and cost-related effects of two large federal nutrition assistance programs (SNAP and WIC) on diabetes outcomes across the life span. Food insecurity is a common, potent factor that leads to type 2 diabetes among low-income populations and contributes to socioeconomic and racial/ethnic difference in health for people with diabetes. We will take advantage of new policies in SNAP and WIC rolling out in California so as to measure the effects of these programs on (a) diabetes care and diabetes complications (such as heart attacks, kidney failure, amputations) among older adults who already have type 2 diabetes, as well as (b) the development of pregnancy-related diabetes or type 2 diabetes or among pregnant mothers and adults with prediabetes, respectively.